Global Infectious Diseases Research Training Program

ABSTRACT
The University of the West Indies Mona Campus and the Ministry of Health, Jamaica have identified the goal
of establishing a Virology Research Program as one of the highest national health priorities. The program
will require training basic, translational and clinical scientists and this will be the responsibility of the Global
Infectious Diseases Research Training Program described in this application. The Global Infectious Diseases
Research Training Program mentoring program was developed during a three-year planning period and will
be led by faculty from the University at Buffalo, Upstate Medical University and the University of the West
Indies. Training will focus on candidates at the University of the West Indies, Mona Campus who are enrolled
in Master's, PhD, and post-doctoral programs. Specific aims include: 1) Create a core of young investigators
by providing a “value added” research training based on a mentored curriculum and core laboratory
experiences that jointly emphasize research design, methods and analytic techniques to address virology
research questions that confront Jamaica, 2) Provide an integrated mentoring program that fosters
innovative research and enhances the trainees' ability to conceptualize and think through research problems
with increasing independence and 3) Develop future research leaders in virology who will establish
extramurally funded research programs and mentor the next generation of graduate students and fellows.
The training objective is to develop 15 independent researchers with expertise in one or more of these areas:
arbovirology, viral hepatitis, chronic viral infection, antiviral drug development, bioinformatics, and laboratory
sciences. This objective will be accomplished by a collaborative approach to mentoring, a customized
curricula based on each trainee's individualized development plan and a Virology Research Skills Toolbox.
Trainees will have short-term periods in US laboratories directed by faculty mentors with extensive
experience in virology, immunology and pharmacology research while completing their research at the
University of the West Indies resulting in capacity building and an independent virology research team. The
proposed GIDRTP will address important public health challenges related to viral disease and be consistent
with current plans for achieving sustainable development goals related to health in Jamaica.

Public health relevance
Narrative: The University of the West Indies Mona Campus and the Ministry of Health, Jamaica have identified the goal of establishing a Virology Research Program as one of the highest national health priorities. The training objective is to develop independent researchers with expertise in one or more of these areas: arbovirology, viral hepatitis, chronic viral infection, antiviral drug development, bioinformatics, and laboratory sciences. The program will address important public health challenges related to viral disease and be consistent with current plans for achieving sustainable development goals related to health in Jamaica.